Postdoctoral Training in Vision Research

Abstract
We propose an Institutional Training Grant to train 8 Postdoctoral Fellows in basic, clinical and rehabilitation
science relevant to translational vision research at the Smith-Kettlewell Eye Research Institute (SKERI).
Eighteen faculty whose expertise spans the areas of spatial and binocular vision, eye movements, strabismus,
central vision loss, low vision and blindness rehabilitation, computer vision and assistive technology are
available to train the postdoctoral fellows. The goal of the Fellowship program is to transition postdoctoral
fellows towards independent research careers by the end of their 2-year fellowship. To this end, the program
encourages the Fellow to develop an independent research project in collaboration with the mentor, to test and
hone these ideas, and distill them into a grant proposal. The training will also provide a solid grounding in rigor
and reproducibility and in the responsible conduct of research, as well as frequent and wide-ranging seminars,
journal clubs and colloquia. Because the vast majority of SKERI Faculty are full-time researchers with no
teaching duties and small laboratories, the Fellows experience a great deal of direct interaction with their
sponsors. In addition, the Fellows have available to them many opportunities for interaction with the rest of the
Faculty, which include basic, clinician and rehabilitation researchers. These interactions are facilitated by the
researchers all being housed within the same building and all working in clinically relevant vision research. The
Faculty-Fellow interactions represent all areas of the research process: proposal, critique, performance, and
communication of findings through the writing of papers and preparation of presentations, as well as
participation in scientific and ethics seminars. Importantly, Fellows are also in frequent contact with each other
through organized events, adjacent open work-spaces, and the numerous collaborations among Faculty. The
Fellowship program forms a critical component of the research vitality and capacity of SKERI. Because SKERI
is not a degree-granting institution, its investigators do not typically have graduate students. It is widely
appreciated within the Institute that Fellows bring in new ideas and techniques to the preceptors’ laboratories.
The process of training Fellows encourages Faculty to challenge old assumptions, to develop clear and
concise descriptions of why a given research activity is of significance, and to expand the range of approaches
to research problems. The T32 Program will significantly augment SKERI’s internally funded Rachel C.
Atkinson Fellowship, C.V. Starr Scholarship Program, and individual Fellowship awards from other sources to
yield an overall program size of approximately 8-10 post-doctoral fellows.

Public health relevance
Public Health Relevance The proposed postdoctoral training program in vision and rehabilitation research will have a positive and direct impact on public health. The program is designed to train fellows to gain a deep understanding of vision and visual impairment to develop novel models of visual function that provide insights into disease prevention, monitoring and treatment, interventions for binocular vision disorders, rehabilitation techniques and assistive devices. Postdoctoral fellows emerging from the program will be able to launch their own independent research careers. Because research at Smith-Kettlewell is motivated by clinical problems, it is highly likely that our fellows will make significant contributions to vision health during and after their training.